Training in Environmental Neuroscience

PROJECT SUMMARY
The proposed Training in Environmental Neuroscience (TEN) is a program based at Florida International
University (FIU), a designated Carnegie Tier I Research University and Hispanic Serving Institution. FIU has a
significant majority (77%) from historically underrepresented populations. Therefore, FIU has a proven record of
recruiting, retaining and graduating minority students, and a leadership committed to providing institutional
resources to ensure successful student outcomes. The TEN program aims to provide training to a new generation
of interdisciplinary scientists working at the unique interface of environmental health and neuroscience termed
Environmental Neuroscience. As the burden of neurological disease and disorders increases at an alarming
rate, especially among underserved minorities, environmental factors are recognized as significant determinants.
Thus, there is an urgent need for a new generation of scientists, especially from Underrepresented Minorities,
trained at the interface of environmental health and neuroscience. The existing Brain, Behavior, and Environment
(BBE) center at FIU is uniquely poised to provide this research training and provides strong institutional support
and home for the proposed program. As a designated Emerging Preeminent Program at FIU, BBE brings
together faculty and students from the Robert Stempel College of Public Health, The College of Arts, Sciences
and Education, the College of Engineering and Computing. The mission of the proposed TEN program is to
provide talented and motivated predoctoral and postdoctoral trainees with rigorous didactic and laboratory
training in contemporary environmental health and neuroscience. Program Objectives are for trainees to 1)
acquire fundamental knowledge in environmental health and neuroscience; 2) become proficient at
integrating concepts of environmental health and neuroscience into cutting edge basic, clinical, and
translational research; and 3) gain the necessary skills and tools to leverage this unique training to
achieve their next career objective. The Program proposes to support a cohort of 2 pre- and 2-post-doctoral
trainees in Year 1, increasing to 3 pre- and 3 post-doctoral trainees/year thereafter. The core curriculum for PhD
students includes didactic coursework in environmental neuroscience, environmental health, neuroscience,
neurotoxicology, advanced methods in neuroscience/neurotoxicology and research design and analysis. This
didactic training is complemented by career development activities, training in Responsible Conduct of Research
and Rigor and Reproducibility, and programmatic/networking opportunities. Postdoctoral trainees will also
participate in selected components of the didactic program, depending upon their background, and be provided
with additional career development activities. At the end of the program, trainees will have a deep
understanding of interdisciplinary Environmental Neuroscience research, demonstrated ability to carry
out independent research in this challenging multidisciplinary area, and achieved state-of-the-art
preparation for this rapidly evolving discipline.

Public health relevance
PROJECT NARRATIVE Florida International University will establish a new Training program in Environmental Neuroscience (TENS) to support high-quality training of pre- and post-doctoral students in the unique and emerging field on neuroscience related to the environmental determinants of both neurodevelopmental and neurodegenerative diseases. As an Institution serving Hispanic and Underrepresented Minority groups, with a proven record of recruiting, retaining and graduating students in STEM (Science, Technology, Engineering, and Mathematics), we will provide a fully inclusive environment for the students to develop innovative technical and professional skills to approach the increasing neurological impacts related to the environment, which is increasingly affecting underserved minorities.